Mechanisms of alcohol's effects on prefrontal cortex circuits

Abstract
The prefrontal cortex (PFC) is essential for moderating drinking and regulating affective changes in alcohol use
disorder (AUD). PFC activity is dynamically modulated by inhibitory interneurons that express vasoactive
intestinal peptide (VIP-INs). Unique among interneurons, VIP-INs preferentially target other inhibitory neurons
to indirectly enhance principal neuron activity. Here, we show preliminary data that chemogenetic stimulation of
PFC VIP-INs reduces social approach behavior in control mice. Conversely, we find that chemogenetic
inhibition of VIP-INs can enhance social preference following chronic drinking (intermitent access, IA ethanol).
Thus, we believe that VIP-INs represent an an exciting cellular target to improve social and affective behaviors
in AUD. Towards that end, the goal of this proposal is to better define the mechanisms through which alcohol
and drinking affects VIP-IN function. One likely mechanism through which ethanol may modulate VIP-INs is by
inhibiting KCNQ channels. Indeed, we provide preliminary data that ex vivo ethanol enhances VIP-IN
excitability in prelimbic (PL)-PFC, that ethanol-induced hyperexcitability is occluded by a KCNQ channel
inhibitor, and that ethanol directly inhibits KCNQ channel currents in VIP-INs but not pyramidal cells. KCNQ
channels assemble as tetramers, and the common KCNQ3 subunit preferentially forms heteromeric channels
with other subunits. Interestingly, we provide evidence that VIP-INs do not express KCNQ3, allowing KCNQ5
and/or KCNQ2 subunits to form heterodimeric KCNQ2/5 or homomeric channels. In this proposal, we
hypothesize that long-term drinking decreases VIP-IN excitability through a homeostatic upregulation of KCNQ
channel function. We will use CRISPR/SaCas9 molecular approaches to systematically test that unique
expression of KCNQ subunits (low KCNQ3 and high KCNQ5) confers VIP-INs with high sensitivity to ethanol
and to its long-term adaptations. Finally, we will test that adaptations to VIP-INs regulate drinking and
associated affective disturbances.
Aim 1: Test that KCNQ subunit stoichiometry governs ethanol’s actions in distinct cell types
Aim 2: Test that long-term drinking alters KCNQ channel function on VIP-INs and ethanol sensitivity
Aim 3: Test that PL-PFC KCNQ channels drive VIP-IN hypo-excitability following IA ethanol and abstinence-
associated affective disturbances
These studies will further characterize how PFC disinhibitory interneurons mediate responses to ethanol and
drinking. The mechanistic CRISPR/SaCas9 approach will provide unprecedented insight into how specific
KCNQ subunits mediate ethanol’s effects in native tissue, with potential to inform and motivate a new wave of
drug discovery or repurposing for AUD medication development.

Public health relevance
Project Narrative New treatments are desperately needed for the persistent symptoms of alcohol use disorder (AUD), including changes in mood and problematic drinking. This proposal is designed to improve our understanding of how acute alcohol and long-term drinking affect specific cells and molecules within prefrontal cortex neural circuits. Our goal is to identify specific molecules that may comprise targets for the development of next-generation medication treatments for AUD.